Structural Characterization of the TOC Protein Translocon Machinery

Project Summary
Infectious diseases cause widespread sickness throughout the world each year and are the second
leading cause of death, particularly in underdeveloped countries. And with the emergence of multi-drug
resistance strains, the necessity for new, more effective, and more sustainable therapies is immediate.
Included in these infectious diseases are the apicomplexa which includes Toxoplasma gondii and
Plasmodium falciparum, the parasites causing toxoplasmosis and malaria, respectively. These parasites
contain a unique plastid-like organelle called an apicoplast which contains four membranes and therefore
have evolved a complex system for importing and exporting proteins across these membranes. These
essential import/export machineries are ideal targets for novel antibiotics against these pathogens. Many
of these translocon machineries are also conserved in other higher eukaryotic organelles such as
chloroplasts and mitochondria, where a large majority of genes are nuclear encoded and therefore must
be imported post-translationally. One such machinery is the conserved translocon of the outer membrane
in chloroplasts (TOC) complex from Arabidopsis thaliana, a model system for studying chloroplast biology.
The TOC complex consists of primarily three components, Toc33/34 and Toc159, both GTPases
containing an N-terminal transmembrane helix anchoring them into the outer membrane, and Toc75, a 16-
stranded β-barrel membrane-spanning translocon. While mechanistic models have been put forth for how
the TOC complex functions, they have remained largely unproven due to the lack of structural
characterization, which is needed to stitch together all the pieces of the mechanistic puzzle. In our studies,
we will use biophysical methods, X-ray crystallography, cryo-electron microscopy, and small-angle X-ray
scattering to structurally and functionally characterize this specialized machinery. Our results will fill a
longstanding gap in the field and will be essential for piecing together the mechanism for how the TOC
complex functions in protein import in apicomplexa and chloroplasts.

Public health relevance
Project Narrative Apicomplexa consist of a large group of parasites that include Toxoplasma gondii (toxoplasmosis) and Plasmodium falciparum (malaria) and contain a unique plastid-like organelle called an apicoplast, containing four membranes and complex systems for trafficking proteins across the membranes. Many of the machineries are conserved in chloroplasts, a model system for studying these large complexes and assemblies. To piece together a mechanistic model for function, we will structurally and functionally characterize the Arabidopsis thaliana chloroplast translocation machinery called the TOC complex.